Understanding Rural Patient, and Provider Preferences for Mobile Lung Cancer Screening Clinics

PROJECT SUMMARY/ABSTRACT
Project 1 (Hasson): Understanding Rural Patient and Provider Preferences for Mobile Lung Cancer Screening
Clinics
Despite the fact that outcomes are best when treatment is given in the early stages of lung cancer, less than
6% of eligible high-risk patients participate in lung cancer screening (LCS), with even lower participation in
rural populations. Data from the National Lung Screening Trial (NLST), a multi-institutional randomized
controlled study of over 50,000 patients, demonstrated the utility of LCS by comparing low-dose computed
tomography (CT) with chest X-ray. It found that LCS with low-dose CT was associated with a 20% reduction in
lung cancer-specific mortality, as well as an overall mortality reduction of 6.7%. Many organizations have
subsequently published guidelines supporting annual LCS. Nevertheless, 10 years later, despite multiple
studies confirming the results of the NLST, and revised guidelines based on continued research into its
efficacy, low-dose CT is still underutilized, and a disproportionate number of high-risk patients are either not
referred or do not undergo screening. While the reasons for this are multifactorial, the need to better
understand the current rural screening landscape, and rural provider and patient barriers leading to low
participation, is imperative to resolve this public health dilemma. Additionally, given these hard-to-reach
locations, use of a community-based approach is vital to developing an intervention that would be well-utilized.
The primary objectives of this proposed study are to identify provider and patient barriers and facilitators that
predict referral to, and utilization of, LCS in rural spaces; assess feasibility and acceptability of mobile clinics
for screening; and test a mobile unit intervention. The proposed approach used to deliver LCS was designed to
reduce logistical and psychosocial barriers. In rural areas, a mobile unit should be feasible and acceptable to
patients and providers, and may serve to supplement traditional hospital or clinic-based screening. Based on
the success of mobile breast and cervical cancer screening programs, the research team seeks to determine
whether a mobile unit will be more successful in increasing screening in rural areas than a traditional hospital-
based approach. This project will develop this hypothesis by: (1) identifying regions with high rates of lung
cancer (and lung cancer identified at later stages); (2) obtaining input from community members to inform a
feasible, acceptable mobile LCS intervention; and then (3) pilot testing a mobile LCS clinic. Findings from this
study will aid in the development of a scalable, feasible intervention acceptable to patients and providers in
rural areas to improve LCS. Further, by understanding the needs of rural communities and enhancing
opportunities for LCS closer to home, earlier detection, prompter treatment, and improved cancer outcomes
can be achieved.